Chronic Intermittent Hypoxia and Hyperalgesic Priming

PROJECT SUMMARY
Sleep is critical to health and well-being, such that current trends towards reduced sleep time and quality,
coupled with rising diagnoses of sleep disorders, negatively affect multiple physiological systems. Increasing
clinical evidence indicates that sleep disorders such as obstructive sleep apnea (OSA) contribute to chronic pain,
with over 40% of sleep disordered patients reporting chronic pain conditions. However, there is a gap in
knowledge concerning how disorders such as intermittent hypoxia contribute to persistent pain. Our long-term
goal is to reduce persistent pain in patients experiencing sleep disorders. As we work towards this goal, the
overall objective of this application is to define the mechanism by which intermittent hypoxia contributes to the
transition from acute-to-chronic pain. Our central hypothesis is that hypoxia from sleep disorders produces
neuroimmune hyperalgesic priming via peripheral macrophage up-regulation. We propose that chronic
intermittent hypoxia stimulates macrophage polarization to increase inflammatory cytokine production in
peripheral nociceptive tissues. Our hypothesis is based on strong evidence utilizing an innovative rodent model
for chronic intermittent hypoxia (CIH) that mimics OSA. The rationale for this work is that increasing our
mechanistic understanding of how intermittent hypoxia contributes to persistent pain could improve quality of life
for tens of millions of American that suffer from sleep disorders. To accomplish our objective, we will test our
central hypothesis with the following related, yet interdependent aims: (1) Identify the location of neuroimmune
interaction, (2) Interrogate the distribution and role of M1/M2 macrophage polarization, and (3) Examine hypoxic
activation of peripheral macrophages. We propose a multi-disciplinary approach to testing our hypothesis,
utilizing transgenic and Cre-Lox recombination mice in biochemical, pharmacological, in vivo imaging and
behavioral protocols with FACS cell sorting and RNA profiling in tandem. Our CIH treatment paradigm is highly
innovative for its translational relevance to human OSA, as is our molecular and biochemical profiling of resident
and infiltrating macrophage populations in hyperalgesic priming. The proposed research is significant because
it will identify novel mechanisms by which sleeping disorders contribute to persistent pain.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because millions of Americans suffer from sleep disturbances that contribute to persistent pain. The mechanisms underlying this contribution are largely unknown and require rigorous, multidisciplinary studies to increase our scientific knowledge of this clinical problem. The project is relevant to NIH's mission because identifying mechanisms that that link the comorbidity of sleep disturbances and persistent pain may result in new complimentary treatment paradigms that improve patient quality of life.